Cytoscape: A Modeling Platform for Biomolecular Networks

This application is being submitted in response to NOT-HG-20-030. We will use data-driven network and hierarchical modeling techniques enabled by Cytoscape ecosystem tools and resources to build models of SARS-CoV-2 infection and will use the models to propose mechanisms of variance in host response based on the analysis of population genetic and COVID-19 disease outcome data. These data-driven models will inform research in population risk stratification and potential COVID-19 therapies. Our models, analysis results, and toolset will be made available to the research community via a website and data repository. The models will be derived from molecular and genetic interaction data and will be used to analyze population data on SARS-CoV-2 infection, comorbidities, and clinical outcomes currently being collected by the UK BioBank. The analysis will be updated periodically with each release of data, maintaining an up-to-date resource for the research community. The modeling tools and pipelines will be user-friendly and well-documented, enabling researchers to build alternative models or to analyze other population data.

Public health relevance
We will identify modules of genes significantly associated with variance in the clinical response to SARS-CoV-2 infection using hierarchical models of SARS-CoV-2 replication derived from protein and genetic interaction networks. The hierarchical modeling process will discover communities of interacting proteins relevant to SARS-CoV-2 infection and the association of those communities with clinical COVID-19 disease outcomes will be tested for significance using pathway-boosted GWAS analysis. Our models, analysis results, and toolset will be made available to the research community via a website and data repository to inform research in population risk stratification and potential COVID-19 therapies.